HEPATOCYTE-DERIVED MIF: A KEY CONTRIBUTOR TO ALCOHOLIC LIVER DISEASE

Alcoholic liver disease (ALD) is a significant cause of preventable morbidity and mortality worldwide. Alcohol-
related morbidity and mortality has remained constant over the past decades, and drinking rates in developed
countries continue to increase. ALD is a spectrum disorder encompassing steatosis, alcoholic hepatitis (AH),
cirrhosis and even progressing to liver cancer. Therapies for ALD, and specifically AH, are unchanged for 40
years as well as ineffective for a significant proportion of ALD patients. Identifying novel biomarkers of ALD
progression and the development of targeted therapies is of marked interest to public health and welfare.
Macrophage Migration Inhibitory Factor (MIF), a ubiquitously expressed regulator of innate immunity with
chemokine- and cytokine-like activities, is associated with ALD in humans and in ethanol feeding models in
animals. MIF is increased in circulation in AH and cirrhosis patients, MIF protein expression is robustly increased
in hepatocytes of AH patients, and MIF is predictive of liver morbidity and patient mortality in AH. In animal
models of ethanol feeding, MIF deficiency protects from ethanol-induced liver injury and normalizes ethanol-
induced inflammation and hepatocyte ER stress. Taken together, these data identified the hepatocyte as a likely
tissue source and site of action for aberrant MIF expression and downstream activity in ALD. The aim of this
proposal is to test the hypothesis that that chronic, excessive alcohol increases hepatocyte MIF release that
acts as a potent upstream regulator of Alcoholic Liver Disease progression through control of
chemokine expression, chemokine packaging, and liver ER stress. The work proposed herein will utilize
tissue-specific MIF knockouts, MIF receptor knockouts and a novel small-molecule MIF inhibitor to interrogate
the role of hepatocyte-derived MIF in multiple alcohol feeding models in animals, ethanol exposure in primary
hepatocyte cultures, and in human ALD patient tissues. Furthermore, the protective phenotype in MIF-deficient
mice is associated with profound changes in chemokine expression in the liver and in circulating extracellular
vesicles (EV). EVs are pivotal intracellular communication mediators, and the chemokine cargoes in EVs are
quite dynamic in both ethanol- and MIF-dependent mechanisms. The other aim of this proposal will then
transition to explore what leads to this increased hepatic MIF expression in ALD. A database search of
mircoRNAs from ALD patient livers (GEO series GSE59492) revealed that a potent negative regulator of MIF
expression, miR-451, is decreased along the spectrum of ALD and was selective to an alcoholic etiology of
disease. The project will then expand to study EVs as a novel mechanism of therapeutic transfer in ALD, as the
proposed studies will look to normalize MIF expression through restoring miR-451 expression as well as
selectively inhibit MIF in the liver.

Public health relevance
PROJECT NARRATIVE Alcoholic liver disease is a major socioeconomic burden in the United States with limited, ineffective therapeutic interventions. This proposal will identify a key tissue source and site of action for a pivotal upstream mediator of pathophysiological liver inflammation following ethanol exposure, macrophage migration inhibitory factor. The results will provide insights to novel therapeutic interventions and diagnostic tools to combat alcoholic liver disease.